Longitudinal Study of Recovery: Psychosocial Functioning, Relapse, and Neuro-Behavioral Markers

PROJECT SUMMARY
Alcohol use disorder (AUD) research typically analyzes relapse and recovery processes over short
time-frames, such as during and immediately following a treatment episode. The long-term trajectories of
recovery, the impact of relapse episodes, and their associated neurobehavioral markers and precipitants
comprise a vital gap in our scientific understanding of the recovery process. Our goals are to provide a
scientific understanding of recovery and relapse, as well as to identify novel targets for future relapse
prevention interventions. Specifically, changes in the mechanisms underlying AUD will be investigated using
the Competing Neurobehavioral Decision Systems (CNDS) framework, which posits that addiction and relapse
arise from a regulatory imbalance between the impulsive and executive decision systems. To pursue this goal,
participants with AUD will be recruited from the International Quit & Recovery Registry (IQRR), which was
established in 2011 and currently has about 8,775 registrants. The IQRR provides a unique online resource
that permits the scientific study of recovery processes and the highly efficient collection of data suitable for
long-term repeated measurement research. We will use an accelerated longitudinal design, which allows the
prospective characterization of psychosocial functioning, relapse, and CNDS functioning across 12 years of
AUD recovery by recruiting participants with a range of different recovery lengths, up to 10 years. Over three
years, participants will complete quarterly assessments, including measures of CNDS functioning. In Aim 1, we
will examine the psychosocial functioning over long-term AUD recovery and how it is impacted by CNDS
regulation. In Aim 2, we will examine relapse over long-term AUD recovery and how it is impacted by CNDS
regulation. In Aim 3 we will examine the dynamic interaction of CNDS processes impacting the recovery using
computational modeling. Together, the findings from this rigorous and innovative research project will improve
our understanding of the temporal dynamics and underlying mechanisms of recovery from AUD.

Public health relevance
PROJECT NARRATIVE The proposed project engages innovative approaches to study individuals recovering from alcohol use disorder using the International Quit & Recovery Registry. This accelerated longitudinal study seeks to characterize long-term trajectories of recovery (0 to 12 years) including the associated changes in psychosocial functioning and relapse status. Findings will inform decision-process theories of addiction and identify treatment targets to promote improved health during recovery.